Virginia Advancing Cancer Control Equity Research Through Transformative Solutions (VA-ACCERT) Center

Overall: Project Summary
The Virginia Advancing Cancer Control Equity Research Through Transformative Solutions (VA-ACCERT)
Center is an academic-public partnership between an interdisciplinary team of investigators from the Virginia
Commonwealth University, Eastern Virginia Medical School, and Virginia’s U.S. Department of Housing and
Urban Development-administered public housing communities. The goal and cross-cutting theme of the VA-
ACCERT Center is to improve dissemination and implementation of health promotion and cancer prevention
services within income-based communities and across the state-wide public housing system in an effort to close
the unjust gaps in cancer health outcomes among marginalized populations. The VA-ACCERT Center will utilize
two essential theoretical models: the Collective Efficacy Mechanism of Action Model to build social capital,
community empowerment, and collective efficacy and elements from the Social Cognitive Theory and Social
Ecological Model to inform multi-level behavioral change. Community members will engage with the VA-ACCERT
Center through these frameworks to aid in the cultural adaptation and delivery of evidence-based intervention
practices, and their participation may include serving on the Housing Collaborative Community Advisory Board,
as Co-Leads and participants in Center-supported research projects, and/or serving as peer-to-peer health
advisors. Led by a Multiple Principal Investigator triad with demonstrable experience in conducting both health
equity and community-engaged cancer control research, the VA-ACCERT Center includes four interdependent
components: a large, five-year, multi-level, interventional Social Drivers of Health Research (SDOH) Project
designed to improve healthy dietary patterns and reduce sedentary lifestyle through gains in low and moderate-
to-vigorous physical activity; a Community Responsive Research Projects initiative that will support the
design, implementation, evaluation, and dissemination of four research projects; a Research Methods,
Measures, and Data Management Core that will provide integral qualitative and quantitative research services
spanning the data management, study coordination, measure development, study or methods adaptation, ethical
considerations, and data sharing for all Center-supported research initiatives; and an Administrative Core
supporting essential internal and external communications and coordination, guided by several advisory entities.
In addition, VA-ACCERT leadership will be engaged in national Consortium-wide efforts involving four other
National Cancer Institute-funded ACCERT Centers and a Central Coordination Center. The VA-ACCERT Center
will also be a hub for growing a more diverse workforce of early-career investigators. These investigators will be
equipped with the skills and support to shape new directions in promoting health equity within income-based
housing communities focused on cancer prevention and control efforts. Ultimately, the VA-ACCERT Center will
disseminate and promote its findings and best practices for wide-scale adoption and sustainability across
income-based housing communities locally and throughout the country.

Public health relevance
OVERALL: PROJECT NARRATIVE The Virginia Advancing Cancer Control Equity Research Through Transformative Solutions (VA-ACCERT) Center fortifies a community-academic partnership between the Virginia Commonwealth University, the Eastern Virginia Medical School, and Virginia’s federally supported, income-based housing communities with the infrastructure to design and conduct multi-level, health promotion and cancer prevention interventions that address the complex social drivers of health that impede cancer health equity in these communities. The VA- ACCERT Center also strives to engage early-career investigators from groups underrepresented in behavioral and biomedical sciences to advance future cancer prevention research among income-based housing populations. Ultimately, the Center will disseminate and promote the adoption of its findings and best practices so they can be adapted to similar income-based housing communities across the United States.